CIRCADIAN VARIATIONS OF ULTRASENSITIVE (TSH) IRMA

The purpose of the project is to determine whether the normal circadian variation of TSH levels occur in amiodarone patients and whether the nocturnal TSH determination may be a diagnostic test for hyperthyroidism.